The Role of Corticolimbic Circuits in Maternal Behavior

PROJECT ABSTRACT/SUMMARY
The transition to motherhood brings dramatic changes in physiology and brain function. This includes changes
to neural circuits regulating maternal care, threat and stress responses, which are essential for the survival and
well-being of the offspring. Human and animal studies highlight the importance of resilient threat and stress
responses to efficient maternal care. Clinical work suggests that improving emotional states of the mother is
promising for engaging more successfully with her progeny. Corticolimbic circuits play a crucial role in threat
and stress responses. However, little is known about the interactions between corticolimbic circuitry and core
maternal brain regions, making it challenging to relate threat and stress responses to maternal care. To
address this gap in knowledge, we recently developed an approach to study corticolimbic brain regions. We
uncovered a distinct subpopulation of neurons within corticolimbic circuits that regulate maternal care, threat
and stress responses in the postpartum state. Our research will yield new insights into corticolimbic regulation
of maternal behaviors by defining the circuit, synaptic function and transcriptional mechanisms using a
combination of genetic technologies, neural-circuit dissection, synaptic electrophysiology as well as
biochemical and transcriptional tools. These approaches allow for a close examination of links between cell-
signaling, synapses and the neuronal nucleus within a specific cell population in relationship to the maternal
state. In Aim 1 we identify cell populations in corticolimbic areas responsible for maternal care and threat
responses postpartum, using chemogenetics, optogenetics, cell-type specific gene promoters, novel knock-in
mouse lines and viral vectors not previously tested in maternal behavior. In Aim 2 we define the synaptic
mechanisms behind maternal behaviors postpartum. We will conduct a detailed analysis of key synaptic
proteins, synaptic transmission and synaptic plasticity in corticolimbic circuits. Accomplishing aim will connect
neural circuits (studied in Aim 1) with synaptic mechanisms that are part of a key intracellular signaling
pathway that supports maternal care and threat responses postpartum. In Aim 3 we make some of the first
measurements of transcription in corticolimbic circuits postpartum. We will examine expression of candidate
genes in relevant brain regions for mothers of our newly developed transgenic mouse lines and compare these
genes to synaptic molecules studied in Aim 2 and to gene databases of human mental disorders with similar
neuronal mechanisms. Accomplishing Aim 3 will provide a mechanistic foundation for connecting corticolimbic
circuits (studied in Aim 1), synaptic proteins and synaptic function (studied in Aim 2) with maternal care and
threat responses and will be a source of new gene targets to test this connection. The results of this work will
guide neural circuit-based, gene-based and pharmacological strategies for improving mothers’ well-being and
their ability to take care of their offspring.

Public health relevance
Project Narrative Corticolimbic circuits play an important role in maternal care, threat and stress responses postpartum, but it is still unknown which neuronal mechanisms connect corticolimbic circuits with core maternal circuits. To this end, we will determine the role of neuroplasticity in a specific corticolimbic circuit, using a multidisciplinary approach that uniquely positions us to address these questions. It will have a significant positive impact on our mechanistic understanding of the neurobiology of the motherhood and may contribute to the design of new therapeutic approaches to prevent and decrease the incidence of mental states with similar neural mechanisms, improving well-being of mothers and their offspring.